Yale Head and Neck Cancer SPORE Developmental Research Program

PROJECT SUMMARY
The primary goal of the Developmental Research Program (DRP) of the Yale SPORE in Head & Neck Cancer
(YHN-SPORE) is to identify and fund innovative pilot projects that possess translational potential to make an
impact in the field of head & neck cancer in the areas of risk assessment, early detection, biomarkers for
prognosis and therapy prediction, mechanisms of carcinogenesis/tumorigenesis, novel therapeutic targets,
development of novel therapeutics, and novel treatment approaches. Investigators of funded developmental
research projects are strongly encouraged to collaborate with other investigators within and outside of the
YHN-SPORE institutions, including other SPORE communities. The purpose is to provide each funded DRP
project with the potential to evolve into independent full SPORE projects or equivalent-scale study proposals.
Ultimately, along with the main YHN-SPORE projects, the outcome from this program will contribute to the
reduction of head & neck cancer morbidity and mortality in the US and worldwide. A DRP Program Award
Committee will be formed and will recruit, evaluate, and select innovative proposals for pilot projects with
translational potential for head & neck cancer. Up to three projects per year will be scientifically and financially
supported by the YHN-SPORE, with regular progress evaluation.

Public health relevance
PROJECT NARRATIVE The objective of this Developmental Research Program is to foster and develop innovative head & neck cancer translational research programs, with objectives that align with the overall goals of the Yale SPORE in Head & Neck Cancer. Projects of the highest caliber will be sought to possibly serve as replacements for the primary SPORE projects if they are completed, or if they cannot otherwise proceed.